Mechanistic Basis of Cardiac Laminopathy

PROJECT SUMMARY
Mutations in the lamin A/C gene (LMNA) encoding structural proteins of the nuclear lamina are responsible for
up to ten percent of cases of inherited dilated cardiomyopathy. The disease is often referred to as cardiac
laminopathy. Experimental evidence partially supports various pathogenic mechanisms of how defects in nuclear
structural proteins cause cardiomyopathy, including that they lead to abnormalities in cell mechanical stability,
dysregulation of gene expression and altered cell signaling. However, there is no unifying hypothesis integrating
these defective processes and explaining exactly how they lead to cardiomyocyte damage and dysfunction. We
recently found a surprising relationship between aberrant extracellular signal-regulated kinase 1/2 (ERK1/2)
signaling and altered nuclear positioning in cardiac laminopathy. This has led us to hypothesize the existence of
a mechanic checkpoint in which alterations in the nuclear lamina upregulate ERK1/2 activity, which causes
mispositioning of the nucleus by phosphorylating and inactivating the actin bundling activity of the formin
homology domain-containing protein (FHOD). Inactivation of FHOD prevents the linker of nucleoskeleton and
cytoskeleton (LINC) complex, which spans the inner and outer nuclear membranes and connects to actin
filaments, to mediate nuclear positioning. Normally, the mechanical checkpoint acts to prevent excessive force
from being applied to the nucleus in contracting cardiomyocytes. However, with permanent alterations in nuclear
structure resulting from LMNA mutations, the persistently activated checkpoint becomes maladaptive, resulting
in abnormal nuclear positioning, nuclear envelope rupture, DNA damage and defects in sarcomere function. This
Project is designed to prove the nuclear mechanical checkpoint hypothesis and determine its role in the
pathogenesis of cardiac laminopathy. In Aim 1, we will examine how activation of the mechanical checkpoint for
nuclear positioning alters cardiomyocyte biology. We will directly measure force on the nucleus using a nesprin-
2 actin tension sensor. As recent data suggest that the nucleus contributes to normal sarcomere, we will test the
hypothesis that persistent mechanical checkpoint activation and nuclear mispositioning leads to defective
sarcomere assembly and function in cardiomyocytes. In Aim 3, we will determine how altering the mechanical
checkpoint affects the heart in vivo. We will test if expressing a phosphomimetic FOHD variant (checkpoint
activation) in the heart induces cardiomyopathy in wild type mouse hearts and if a non-phosphorylatable variant
(checkpoint inactivation) ameliorates pathology in a mouse model of cardiac laminopathy. Proving the existence
of a novel nuclear mechanical checkpoint and establishing its role in the pathogenesis of cardiomyopathy caused
by LMNA mutations will shift research directions in the field and potentially lead to new treatments for this life-
threatening inherited heart disease.

Public health relevance
NARRATIVE Mutations in the lamin A/C gene cause a severe type of heart dysfunction called dilated cardiomyopathy. The goal of this project is to investigate a novel mechanism that may normally protect heart muscle cells from mechanical forces but lead to damage when persistently activated in patients with lamin A/C gene mutations. This fundamental research could uncover new ways to treat this life-threatening inherited heart disease.